Massively-parallel functional interrogation of genetic variation in LGMD-associated sarcoglycan genes

PROJECT SUMMARY
Mutations in α-, β-, γ-, and δ-sarcoglycan cause sarcoglyanopathies, a subset of limb-girdle muscular dystrophy
(LGMD) with devastating effects for patients including muscle wasting, progressive weakness, degeneration of
skeletal muscle and often premature death. Accurately diagnosing patients with LGMD before symptom onset
or early in the course of the disease has the potential to enable the use of preventative gene therapy or other
therapeutics and in the majority of cases can only be done in presymptomatic cases through genetic testing.
When a new DNA variant in one of these genes is observed in a patient, however, there is often insufficient
evidence to classify it as pathogenic. Within this study, we will use a new approach to express and characterize
every possible missense variant in the SGCA, SGCB, SGCG and SGCD genes to advance our understanding
of sarcoglycan biology, improve the interpretation of genetic variation in the SGC genes, and advance LGMD
care and treatments. We will employ deep mutational scanning, a method for measuring the effects of massive
numbers of missense variants of a protein simultaneously. We will express a library of all possible SGC missense
variants in cultured human cells and measure the effect of each by exploiting a simple but robust characteristic
of pathogenic SGC gene variants, disruption of proper protein trafficking. Our two aims are: 1) Quantifying the
effect of nearly every possible SGC missense variant on SGC protein trafficking and membrane localization, and
2) Predict and validate the pathogenicity of every possible SGC missense variant by integrating multiple
functional assays from Aim 1 to create a pathogenicity score for each variant and by confirming variant
predictions biochemically using tissue samples from LGMD patients with VUS. These aims will reveal how each
possible missense variant in SGC genes impact expression, transport, function or interaction with other SGC
proteins. The functional data we generate, the analyses we propose, and tools we build will transform the
characterization of SGC variants. They will also serve as a resource to better understand sarcoglycan biology,
improve the clinical translation of sarcoglycanopathies and LGMD using genetic information, and inform new
treatments.

Public health relevance
The goal of this project is to develop a method to reliably predict the consequences of genetic variants of unknown significance discovered in the course of genetic testing in a subset of Limb-girdle muscular dystrophies caused by mutations in the sarcoglycan genes SGCA, SGCB, SGCD and SGCG. We propose to use an integrated experimental and computational approach that combines multiple high-throughput assays of protein trafficking and function and machine-learning to generate pathogenicity predictions for all possible single- nucleotide variants in these SGC genes and then to validate our predictions in primary tissue samples from patients with SGC variants.